Simultaneous profiling of neuronal synapse activities, proteins, and messenger RNAs at the single-cell level

PROJECT SUMMARY
Autism spectrum disorder (ASD) is a debilitating neurodevelopmental disease that severely affects cognition
and communication in patients. Genome-wide association studies of ASD have revealed complex polygenic
variation in synapse-associated proteins. The normal development and function of neuronal circuits rely
critically on the spatially controlled expression and regulation of synaptic proteins, their messenger RNAs
(mRNAs), and their interactions. Thus, understanding how penetrant genetic variations associated with
neurodevelopmental diseases such as ASD impact neuronal synapse development, homeostasis, plasticity,
and activity is crucial for the identification of new therapeutics to treat patients. Toward this end, single-cell
fluorescence imaging of neuronal synapse activity integrated with in situ measurement of synapse protein and
mRNA levels and localizations offers the potential to identify convergent synaptic phenotypes in ASD. The
present project builds on prior research in which we applied highly multiplexed fluorescence imaging of
synaptic proteins to fixed neuronal samples to identify convergent synaptic phenotypes associated with ASD
and SCZ risk genes. Specifically, we build on this technique by integrating high-throughput molecular
characterization of mRNA expression levels and localizations in intact neurons together with characterization of
neuronal activity in the same cells. Live-cell imaging of glutamate and calcium levels is performed followed by
fixation and multiplexed fluorescence imaging of both multi-protein and mRNA levels and localizations
including mRNA translational state. CRISPRi will be used to characterize how high confidence ASD-associated
gene deletions affect neuronal synapse activities and their multiprotein-mRNA interaction networks. Bayesian
network analysis will identify convergent networks and pathways by which ASD-associated genetic variations
impact neuronal function both in rodent and human iPSC-derived neuronal cultures, in collaboration with the
Stanley Center at the Broad Institute of MIT and Harvard. Development of this multi-modal synapse
characterization approach will pave the way towards the discovery of new therapeutics for ASD, as well as
other neurodevelopmental disorders such as SCZ using patient samples in future work.

Public health relevance
PROJECT NARRATIVE Neurodevelopmental diseases such as autism spectrum disorder have major health impacts in the US. Understanding how complex polygenic variations associated with these diseases affects neuronal activity in human patient populations is crucial to the identification of new therapeutics to treat these debilitating diseases.